TRANSPLANTATION OF HUMAN NEVI TO NUDE MICE

The objective of this project is to create an animal model of human dysplastic nevi. Dysplastic nevi are known precursors to melanoma. Specific aims are: 1) to characterize the histopathology of these nevi following transplant, 2) to attempt to increase the degree of dysplasia with UV-irradiation, and 3) to attempt to decrease dysplasia with proposed melanoma chemopreventive agents.